Immunomodulatory ligand B7-1 targets p75 neurotrophin receptor in neurodegeneration

The aging brain is characterized by a slow deterioration of homeostatic balance between pro- and anti-inflam-
matory cytokines, resulting in a proinflammatory state. Resident CNS immune cells are normally present in a
resting state, but exhibit heightened vulnerability to secondary insults with aging, leading to a phenotypic shift in
cell surface marker expression and cytokine release that contribute to the proinflammatory state. The functional
contributions of interactions between cell surface proteins of neurons and immune cells have not been fully
addressed. Using an unbiased protein-protein interaction screen, we determined that the immunomodulatory
ligand B7-1 (CD80) interacts with the p75 neurotrophin receptor (p75). Importantly, the B7-1:p75 interaction is
of recent evolutionary origin, present only in primates, although exogenously applied human B7-1 (hB7-1) binds
murine p75 due to the extensive conservation of p75. We mapped the B7-1 surface responsible for p75
engagement and demonstrated that it includes regions known to interact with CTLA-4/CD28 and extends to
additional surface regions. Given this overlap, CLTA-4/CD28 directly compete with p75 for binding to hB7-1.
Exposure of murine hippocampal neurons in vitro to hB7-1 acutely alters dendritic and spine morphology, with
loss of postsynaptic protein PSD95 and microtubule discontinuity in a p75-dependent manner. Abatacept, an
FDA-approved therapeutic protein (CTLA-4-Fc), inhibits these effects. In vivo injection of hB7-1 into the murine
subiculum, a hippocampal region affected in Alzheimer’s Disease, results in acute p75-dependent pruning of
dendritic spines. To study the effects of hB7-1 in the intact animal, and in models of neurodegeneration, we
developed a chimeric humanized B7-1 knock-in mouse. Our long-term goal is to develop monoclonal antibodies
that specifically block hB7-1:p75 engagement for the prevention of neurodegeneration, and we have identified two
such monoclonal antibodies that block hB7-1:p75 synapse elimination at 10nM concentration. Aim 1 will further
evaluate and prioritize these and other monoclonal antibodies to develop additional reagents with broad epitope
coverage. In Aim 2, our two lead antibodies, and other prioritized antibodies, will be evaluated using hippocampal
neuron cultures for effects on blocking synaptic elimination and negative dendritic remodeling. Aim 3 will evaluate
the in vivo effectiveness of select antibodies on preventing hB7-1 spine elimination and behavioral impairment by
blocking the interaction of immune cell-expressed B7-1 with neuronal p75 in WT, chimeric B7-1 and an AD mouse
model. These studies represent conceptual, mechanistic and therapeutic advances by (1) extending our
understanding of immune:neuronal interactions that promote neurodegeneration; (2) identifying mechanisms that
exist in humans, but not mice, to overcome existing limitations of murine models; (3) identifying preclinical
therapeutics for aging populations.

Public health relevance
Immune cell: neuronal interactions contribute to the neuroinflammatory process which underlies aging and many neurodegenerative diseases. Our identification of the immunoregulatory protein B7-1 as a ligand of neuronally expressed p75 receptor provides a new therapeutic target. Here, we develop preclinical monoclonal antibodies that block the neurodegenerative actions of B7- 1:p75 engagement.